Clarifying the role of tobacco retail outlets on maternal smoking during pregnancy and child secondhand smoke exposure

Abstract
Both smoking and second hand smoke (SHS) exposure are established risk factors for chronic disease and
cancer. While the prevalence of smoking has decreased in the population as whole, there are subgroups that
are particularly vulnerable to smoke exposure, such as pregnant women and children, and it is recommended to
eliminate exposure almost entirely among these subgroups. Many states are active in either planning or
proposing new regulations limiting tobacco retail outlet (TRO) density as a means of reducing smoking.
Presumably, reducing TRO density should lead to lower levels of adult smoking, which should also reduce
maternal smoking during pregnancy and SHS exposure in children. There is scant evidence that TRO density is
related to smoking behaviors, and there is no evidence showing that reducing TRO density will extend to
vulnerable subgroups and those passively exposed, like pregnant women and children. The purpose of proposed
study is to examine the extent to which TRO density is related to biomarkers of smoke exposure (cotinine) in
1000 women during their pregnancy and in 400 children aged 4-10 born of these mothers. In addition, the study
will determine the degree to which cotinine levels and TRO density relate to health care utilization and costs
during pregnancy and early childhood. To accomplish this study, the team will integrate data on biomarkers of
smoke exposure and health-care utilization data from a longitudinal pre-birth cohort with publically available data
sources on TROs and census data (American Community Survey). By better understanding the link that TROs
have with smoke exposure and the related health-care costs associated with such exposure, we will be better
positioned to make data-driven policies that aim to modify the TRO landscape. Successful completion of this
project will provide evidence supporting continued efforts to expand policies reducing TRO density and retain
them where they are being enacted.

Public health relevance
Project Narrative This study will leverage biological and health services data from a pre-birth cohort and integrate it with census data and geospatial data on tobacco retail outlets with the purpose of determining the extent to which tobacco retail outlets relate to smoke exposure and related health care costs.